Development and Validation of a Rodent FES Bicycle System

Bone loss is a hallmark of severe spinal cord injury (SCI) that increases risk of fracture and contributes to the
development of medical comorbidities that worsen mortality risk. The bone deficits occurring after SCI are
precipitated by the central nervous system (CNS) insult and the subsequent musculoskeletal unloading, which
has resulted in an emphasis on activity-based physical therapy (ABPT) modalities that reload the impaired
limbs to restore bone integrity. Strategies that couple ABPT with electrical stimulation [e.g., functional electrical
stimulation (FES) cycling] are intriguing because they improve muscle recovery in the impaired limbs by
stimulating muscles to perform task-specific exercise and may promote sensorimotor recovery in the presence
of some spared spinal tracts. However, the ability of FES cycling to restore bone mineral density (BMD) in the
paralyzed limbs remains contentious after SCI, especially at the distal femur and proximal tibia sites that are
most prone to fracture. These data indicate need to optimize FES parameters for bone restoration. The goal of
this proposal is to develop and operationalize the first-ever ‘humanized’ FES bicycle system for rats. We will
then use our system in future proposals to optimize FES parameters for bone recovery in a ‘high-throughput’
manner, using our rat severe SCI model that exhibits similar musculoskeletal pathophysiology to persons with
severe traumatic SCI. To achieve our goal, we propose a novel high-risk / high-reward approach that will
reverse-translate the design of a human FES bicycle to develop a FES system for rats consisting of 1) a rat
bicycle that allows both FES directed and motorized pedaling on a crank shaft with modifiable resistance
levels, 2) sensors that record pedal locations, torque, velocity and that provide real-time feedback on these
pedaling parameters to a FES control system and a camera that records limb motions, and 3) a closed-loop
switched control system that accurately regulates pedaling between FES, in positions where muscles
contribute to pedaling, and an electrical motor coupled to the bicycle crank shaft that initiates in FES “dead
zones” where muscle activity provides little pedaling contribution. Our approach is innovative because, if
successful, it will provide a cost-effective and time-efficient means to optimize preclinical FES parameters for
bone restoration, which can then be fast-tracked to clinical trials that will assist in developing personalized
rehabilitation strategies for Veterans with SCI. To ensure our success, we have taken key steps, including: 1)
constructing a motorized (passive) rat bicycle that serves as the platform for our hybrid FES directed /
motorized cycle, 2) developing a closed-loop switched control system for human FES cycles that serves as a
model for our control system, and 3) characterizing the locomotor, bone, and muscle deficits in our rat severe
contusion SCI model, which we will use to test and validate the FES bicycle. Moreover, we have demonstrated
that motorized (passive / isokinetic) cycling normalized reflex excitability and promoted locomotor and bone
recovery (Preliminary Data) in SCI rats, providing rationale for cycling as the base ABPT modality in our
proposal. While these components are in-place, our proposal remains high-risk / high-gain because success
requires that we modify our existing rat bicycle, as described above; that we design, fabricate, model, and
optimize a closed-loop switched control system that accurately regulates pedaling cadence in rats; and that we
explore initial tolerability to repeated FES cycling bouts in our rat SCI model. Based on our findings, system
refinement and re-testing may also be required. To address these steps, we have two Aims:
Aim 1: Design and fabricate a rat bicycle and a closed-loop switched control system that alternates
FES directed and motorized control of the crank shaft to produce continuous pedaling.
Aim 2: Operationalize, validate, and test our FES bicycle system in rats with severe SCI.

Public health relevance
More than 42,000 individuals with spinal cord injury (SCI) are eligible for treatment in the VA Healthcare System, with direct healthcare expenditures exceeding $716 million/year. Bone loss is a hallmark of severe SCI that produces 20- to 100-fold higher fracture risk, with extended post-fracture hospitalization. Moreover, the risk for respiratory illness, venous thromboembolic events, pressure ulcers, urinary tract infections, and other medial comorbidities more than doubles in persons with SCI within 1-month of fracture, which contributes to the 30% higher 5-yr mortality risk that exists for those with versus without fracture after SCI. Despite these consequences, no physical rehabilitation regimen or pharmacologic therapy has been shown to consistently improve BMD recovery after SCI or to completely prevent bone loss at the most fracture prone sites in this population. These findings provide strong justification for studies that focus on identifying and optimizing strategies to improve skeletal integrity and reduce fracture incidence in Veterans with SCI.